Computational Genomics (CG-SR)

Computational Genomics Shared Resource (CG-SR)
Project Summary
The Computational Genomics Shared Resource (CG-SR) incorporates both bioinformatics and genomics
expertise for the Purdue Center for Cancer Research (PCCR). The greatest utility of the CG-SR is in data
analysis. Since 2015, the CG-SR has analyzed dozens of projects, of which the majority are bulk and single-cell
RNA sequencing (RNA-seq), whole genome sequencing (WGS), chromatin immunoprecipitation sequencing
(ChIP-seq), whole genome CRISPR-Cas 9 screens, and bisulphite sequencing. Since its inception in 2015, the
bioinformatics services provided by the CG-SR has supported 45 PCCR investigators' research projects (23 in
the last year) from all three of PCCR's Research Programs. The analyses performed by the CG-SR are highly
customized and tailored to individual groups, providing PCCR members with fast, reliable, and high-quality data
analysis. The incorporated genomics consulting services provide equal access to all PCCR members and have
served 53 PCCR members in the last year. The CG-SR aids in experimental design, ensuring that the
experiments carried out by PCCR members are feasible, provide adequate power, and follow experimental
guidelines suggested in the scientific literature. The CG-SR regularly participates in writing grants and
manuscripts with PCCR members. In this way, the PCCR members are supported by the CG-SR from the initial
stages of a project, all the way through publication. Finally, the CG-SR provides both formal and informal
bioinformatics training and support for PCCR members. The CG-SR currently mentors four trainees (three
graduate students and one undergraduate student) and prepares both computationally and biologically inclined
graduate students to bridge the gap between computational and biological disciplines. The CG-SR aided in
designing and teaching a course to encourage life scientists to use high-performance computing resources on
campus and to teach them the basic skills that are necessary for such work. The CG-SR regularly gives talks
and workshops on campus, and provides group and one-on-one training for labs, students, postdocs, and faculty
who wish to learn to perform their own data analysis.